Mechanism of metabolic remodeling in the diabetic heart

PROJECT SUMMARY
To compensate for the decreased glucose oxidation, diabetic cardiomyocytes increase lipid uptake. Due to
mitochondrial dysfunction, cardiomyocytes could not efficiently utilize lipids leading to accumulation of fatty acetyl
CoA, a product of fatty acid oxidation. High levels of acetyl CoA promotes ketogenesis by inducing the rate-
limiting enzyme 3-Hydroxy-3-MethylGlutaryl-CoA-Synthase-2 (HMGCS2), which produces ketone bodies.
Ketogenesis inhibits consumption of ketone bodies via ketolysis where the rate-limiting enzyme is succinyl-CoA:
3-oxoacid CoA transferase (SCOT). Reduced ketolysis decreases energy in the diabetic heart. In our novel
diabetic Akita mice with cardiac-specific overexpression in the cardiomyocytes (Akita/miR-133aTg), intramyocyte
lipid accumulation is prevented. Our investigation revealed that miR-133a targets 3/UTR of Zinc finger E-box-
bonding homeobox (ZEB). ZEB inhibits mitochondrial deacetylase sirtuin-3 (SIRT3). SIRT3 improves
mitochondrial function by activating mitochondrial proteins via deacetylation. Increased mitochondrial function
decreases the fatty acetyl CoA accumulation, which is required for both ketogenesis and lipid accumulation.
Hypothesis: Overexpression of miR-133a in the DM heart will promote fatty acid metabolism to decrease lipid
accumulation and ketogenesis, which overall stimulates ketolysis resulting in improved energy efficiency.
Aim 1: Test the hypothesis that increased cardiac miR-133a improves fatty acid metabolism to reduce
lipid accumulation in the diabetic heart by targeting ZEB. Evaluate the effect of miR-133a on diabetes-
induced FA uptake and metabolism, ZEB, and lipid accumulation in the diabetic heart.
Aim 2: Test the hypothesis that increased fatty acetyl CoA in mitochondria induces ketogenesis in the
diabetic heart by upregulating HMGCS2. Evaluate the effect of SIRT3 on fatty acetyl CoA, HMGCS2, and
ketogenesis in the diabetic heart.
Aim 3: Test the hypothesis that cardiac ketogenesis prevents ketolysis to reduce energy in the diabetic
heart by suppressing SCOT. Evaluate ketolysis and cardiac energy in the HMGCS2-inhibited diabetic heart.
Impact: The completion of these aims will: 1) enhance our knowledge on metabolic remodeling in the DM
heart, 2) provide new molecular targets to modulate metabolic flux in the DM heart, 3) provide insight to
improve cardiac energy efficiency in the diabetic heart, and 4) render metabolic targets that can be tested in
non-diabetic heart failure where metabolism is deranged.

Public health relevance
NARRATIVE Diabetes and cardiometabolic syndrome are highly prevalent in the USA and increases the risk of heart failure. In this proposal, we will reveal new regulators of metabolic remodeling at the molecular level and develop a novel therapeutic target to restore cardiac energy efficiency and reduce the risk of heart failure in diabetes.